Multi-Omic Analysis of Phthalate Exposure and Early Life Risk of Type 2 Diabetes.

Project Summary
The rise of youth onset Type 2 Diabetes Mellitus (T2DM), one of the most common endocrine
diseases, is an important public health concern. Current methods to identify risk of T2DM are
neither specific, such as screening for elevated body mass index (BMI), nor sensitive. Most risk
factors are thought to be related to lifestyle and do not account for environmental chemical
exposures or individual variation in biological response to lifestyle and chemical exposures.
Despite this, evidence has emerged that links endocrine disrupting chemicals such as phthalates
to T2DM. Phthalates are a class of human-made compounds found in plastics and fragrances.
However, analyses linking gestational phthalate exposure, an important window of
susceptibility, to endocrine disruption and disease risk later in life are sparse and rely on non-
specific anthropometric outcomes such as BMI. The use of multi-omics data in epidemiological
research can help to identify biomarkers of disease and predict disease development, such as
elevated fasting blood glucose, before clinical symptoms occur, and quantify inter-individual
differences in disease risk. Epigenomics is the measurement of environmentally modifiable
chemical marks on DNA and chromatin which regulate gene expression. Metabolomics,
measurements of compounds circulating in the blood, provide a real-time view of metabolic
activity. These analytes may elucidate early markers of disease development and potentially
serve as biomarkers of disease. The central hypothesis of this work is that changes to
the epigenome and metabolome are predictive of blood glucose dysregulation in
adolescence, and that gestational exposure to phthalates increases this risk. We
address this hypothesis in the Early Life Exposures in Mexico to Environmental Toxicants
(ELEMENT) longitudinal birth cohort study. Aim 1 focuses on understanding the effect of
maternal phthalate exposure on the offspring epigenome and how maternal nutrition interacts
with phthalates to alter the epigenome. Aim 2 applies novel computational techniques to
epigenomic and metabolomic data to predict adolescents at elevated risk for elevated fasting
blood glucose. Overall, this study will contribute to the scientific knowledge base about
potentially preventable exposures that contribute to T2DM development and biomarkers to
improve early screening efforts. Completion of this research along with the proposed training
plan will equip me with a highly specialized skillset to leverage data science techniques and
include omics, nutrition, and toxicant exposure in precision environmental health research.

Public health relevance
PROJECT NARRATIVE Modern daily life requires that we interact with a multitude of toxicants, but the risk of these exposures during pregnancy to future generations is not well known. To study exposure to a class of endocrine disrupting chemicals, phthalates, and identify risk of diabetes development, multi-omic data can inform the systems-level effect of these exposures across the lifespan with more precision than traditional approaches. In this study, we take a precision environmental health approach to incorporate high dimensional epigenomic and metabolomic data, machine learning, and advanced statistical approaches to understand possible drivers of the relationship between prenatal exposure to phthalates, the maternal diet, and potential biomarkers of diabetes development in adolescents who may be at higher risk of this disease.